Sonogenetic Remote Control of Cellular Function

SUMMARY
The discovery and development of fluorescent proteins and optogenetics revolutionized biology by making it
possible to image and control specific cellular processes with visible light. While these tools have enabled
countless biological discoveries, the poor penetration of light into living tissue makes it difficult to use optical
techniques in intact animals. As a result, biological phenomena ranging from the signaling of neurons in deep-
brain regions, to the infiltration of immune cells into tumors, to the microbial colonization of the GI tract, are
challenging to study within their natural in vivo context. If instead of light it were possible to visualize and
manipulate cellular function using a more penetrant form of energy such as ultrasound, this would open
previously inaccessible domains of in vivo biology to direct investigation. In addition, it would enhance the
development of cell-based therapies by allowing cellular agents to be seen and controlled after administration
into the human body. The physics of ultrasound make it an ideal modality for deep-tissue cellular communication.
Sound waves in the MHz range are weakly scattered by tissue and can therefore penetrate several cm into the
body. With wavelengths on the order of 100 µm and travel times < 1 ms, ultrasound can access many key
structures and processes. When focused, sound waves can deliver mechanical and thermal energy to precise
anatomical locations. These properties have already made ultrasound one of the world’s most widely used
technologies for medical imaging and non-invasive surgery. However, the potential of ultrasound to serve as a
tool for cellular imaging and control has been relatively untapped due to a lack of methods to connect it to the
function of specific cells and biomolecules. In previous work, the Shapiro lab has pioneered the use of ultrasound
in cellular and molecular imaging by developing the first acoustic reporter genes and biosensors for ultrasound,
aiming to “do for ultrasound what fluorescent proteins have done for fluorescence microscopy”. The major goal
of our proposed new research direction is to “do for ultrasound what optogenetics has done for light” by giving
sound waves the ability to control specific cellular functions such as neuronal excitation, gene expression and
intracellular signaling in vivo. The basic principle of our approach is to (1) use focused ultrasound to deposit
acoustic energy at a specific location in tissue, (2) use genetically encoded “acoustic antennae” to convert this
energy into local mechanical force, and (3) use this force to actuate mechanosensitive receptors to produce
specific cellular signals. We will implement this approach in neurons and immune cells to enable unique
neuroscience and cell therapy applications. If successful, this work will help establish the new field of
sonogenetics by providing researchers and clinicians with the unprecedented ability to “point and click” on cells
deep within the body and tell them what to do.

Public health relevance
NARRATIVE To study biological systems in their critical in vivo context and develop effective cell-based therapies, we need new methods to manipulate the function of cells deep inside living animals. In this project we will develop a technology that enables cellular remote control with ultrasound – a form of energy that can be targeted non- invasively to deep tissues with sub-millimeter spatial precision. This technology will use genetically encoded “acoustic antennae” to convert ultrasound into local mechanical force and apply it to engineered mechanosensitive receptors, triggering desired cellular pathways for remote-control of neural activity and immunotherapy.